A Novel Strategy to Identify Protective T cell Epitopes for HPV Therapeutic Vaccine

PROJECT SUMMARY I am a molecular immunologist fascinated by T cell immunology. My scientific interest is
applying molecular and computational approaches to study the human T cell repertoire and antigenic epitopes
during infection. In prior research, I acquired skills and knowledge that are highly aligned with my interests, which
resulted in consecutive first-author publications in prestigious journals, including Immunity, Cell Reports, and
Frontiers in Immunology. My short-term goal is to become an assistant professor and start my independent
research. My long-term goal is to become a leading scientist in T cell recognition. Stanford University provides
the best possible training environment through world-leading faculty, facilities and resources to fulfill my career
goals. My postdoc mentor, Dr. Mark M Davis, has been a world-leading T cell immunologist since 1980s. He has
mentored over 70 postdocs and most are on tenure-track positions at renowned universities. My career training
will be under the close guidance of Dr. Davis as well as my Advisory Committee with five outstanding senior
professors from Stanford, Yale and MIT, who are Drs. Calvin Kuo, Akiko Iwasaki, Darrell Irvine, Benjamin Pinsky,
and Holden Maecker. Each of them and I have developed an individualized research training and career
development plan. My training will focus on advanced methodologies and knowledge, academic activities, faculty
job hunting, grant application, scientific publication, laboratory management, and long-term collaborations.
This proposal will focus on the identification of protective T cell epitopes that have potential to formulate HPV
therapeutic vaccine. Most vaccines prevent viral infection effectively by inducing neutralizing antibodies, but they
fail to eliminate pathogens post-infection, one such example is the existing HPV vaccines. It’s striking that while
most HPV-infected females clear the virus naturally, many do not and progress to cervical cancer. T cells are
the complements of antibody responses to maintain host immune competence. We recently found that there is
a small fraction of T cell specificity groups uniquely enriched in females who cleared HPV. It is worth noting that
this pattern is similar to what our group found in the control of Mtb (Nat Med, 2023). Thus, I hypothesize that
there are unique T cell specificity groups in HPV-infected females that correlate with HPV clearance, and T cells
that contribute to clearance are subdominant during infection. This is a critical question as prior studies on
protective T cells largely focus on dominant T cells. The identification of T cell epitopes is technically challenging,
especially for those recognized by subdominant T cells. Moreover, as the T cell response is MHC restricted, it is
a longstanding barrier to probing T cell epitopes with appropriate experimental models. I am proposing to tackle
these problems with cutting-edge technologies, this study will comprehensively cover T cell receptor (TCR)
sequencing, protective TCR discovery, T cell epitope identification and the establishment of probing models. The
novel concepts and the knowledge generated in this study will pave a path to identify protective T cell epitopes
for T cell-based vaccines, not only for combating HPV infection but also for viral infection in general.

Public health relevance
PROJECT NARRATIVE Given the large burden of existing global HPV infection cases (>200 million), the development of a therapeutic vaccine that is able to clear HPV infection in infected females would have a major health impact and is highly aligned with part of the NIH’s mission. T cell-based vaccine is a promising strategy to design therapeutic vaccines against HPV and the identification of protective T cell antigenic epitopes is the basis of the rational design of HPV T cell-based therapeutic vaccines. This proposed study will establish a novel strategy with cutting-edge technologies to pave a path to identify protective T cell epitopes for T cell-based vaccines, not only for HPV infection but also for viral infection in general.